DCE-MRI guided Neoadjuvant Chemotherapy for Borderline Resectable Pancreatic Cancer

PROJECT SUMMARY / ABSTRACT
Choosing the more effective therapy is imperative for borderline-resectable pancreatic cancer (BRPC). BRPC is
a subcategory of pancreatic adenocarcinoma (PDAC) (about 20% of the entire PDAC cases). BRPC contacts
peripancreatic arteries and/or veins but has the potential to be successfully resected after downstaging with
effective neoadjuvant therapy. Currently, there are two first-line therapeutic options for BRPC patients, nab-
paclitaxel with gemcitabine and FOLFIRINOX. Overall response rates of these regimens are comparable (20-
30%), and there are no robust data favoring one over the other.
Dynamic contrast-enhanced magnetic resonance imaging (DCE-MRI) has the potential as a non-invasive tool
for early evaluation of PDAC response to chemotherapy. PDAC is typically hypo-perfused due to significant
tumor sclerosis creating elevated interstitial pressure and consequently compressing tumor-feeding vessels.
However, an effective therapy induces acute necrosis, reducing interstitial pressure and increasing perfusion.
As DCE-MRI can measure tissue perfusion by monitoring the dynamic change of MRI contrast agents introduced
intravenously, it can detect perfusion increase in responding PDAC before the morphological change of tumors.
However, variability in quantitative DCE-MRI measurement remains a concern.
We developed a perfusion phantom named P4 (Point-of-care Portable Perfusion Phantom) to reduce the
variability in quantitative DCE-MRI measurement. The reproducibility of quantitative DCE-MRI measurement
(e.g., volume transfer constant: Ktrans) of various abdominal tissues across three MRI scanners significantly
increased after P4-based error correction (Intraclass correlation coefficient: 0.39 vs. 0.98).
We demonstrated that quantitative DCE-MRI could be used to identify the early therapeutic response of PDAC
after P4-based error correction. In our pilot study, DCE-MRI was applied for 20 PDAC patients before and 6-8
weeks after therapy initiation. The Ktrans of pancreatic tumors favorably responding to chemotherapy increased
84±26% (n=11) after P4-based error correction, while that of non-responding tumors did not (-7±11%) (n=9)
(p<0.0001). We achieved 100% accuracy in differentiating between responding and non-responding tumors.
We hypothesize that DCE-MRI-guided neoadjuvant chemotherapy will improve the negative margin (R0)
resection rate for BRPC patients when the P4 is used for correcting errors in the imaging data. We propose to
switch the first-line therapeutic regimen to the second one if the Ktrans in the tumor increases more than the
threshold. We will compare the R0 resection rate of the group that received DCE-MRI-guided neoadjuvant
chemotherapy with that of the historical control group that received standard-of-care treatment (primary endpoint).
Also, we will determine whether quantitative DCE-MRI can be a reliable tool for assessing pancreatic tumor
microenvironment after P4-based error correction using digital histopathology (secondary endpoint).

Public health relevance
PROJECT NARRATIVE We invented a Point-of-care Portable Perfusion Phantom (P4), which allows reproducible quantitative DCE-MRI measurement across MRI platforms. We demonstrated that quantitative DCE-MRI after P4-based error correction could assess the pancreatic cancer response to therapy early. In this study, we propose a clinical trial of DCE-MRI-guided neoadjuvant chemotherapy to improve the negative-martin resection for patients with borderline resectable pancreatic cancer.